A culturally grounded approach to understanding and improving Alzheimer'sdisease and related dementia (ADRD) knowledge, attitudes, and behaviors forAmerican Samoan family caregivers

ABSTRACT
Alzheimer’s Disease and Related Dementias (ADRD) are progressive neurodegenerative
disorders that include impairments in cognitive ability and overall functioning and have
devastating impacts on both individuals living with ADRD and their families. Native Hawaiian and
Pacific Islanders (NHPI) are among the fastest growing racial/ethnic groups in the United States,
and Samoans are the 2nd largest NHPI sub-population. In American Samoa, a U.S. territory with
90% of the population identifying as Samoan, there is pressing concern about ADRD due to a
growing elder population disproportionately affected by ADRD risk factors including obesity,
hypertension, and type 2 diabetes. The at-risk age group and their family caregivers (hereafter
“caregivers”) face complex challenges due to low health literacy, low education, and limited
access to formal support services. Evidence suggests that caregiving for someone with ADRD is
more taxing than other medical conditions and often corresponds with increased anxiety,
depression, and poorer quality of life for the caregiver. Despite their critical role, little is known
about the experiences of Samoan caregivers creating a knowledge gap that forestalls
development of culturally appropriate ADRD interventions. Our overarching OBJECTIVE is to use
a culturally grounded, explanatory sequential design to assess ADRD knowledge, attitudes and
behaviors (KAB) of caregivers in American Samoa as a prelude to future interventions to better
meet community needs. Our SPECIFIC AIMS are: 1) Determine caregivers’ ADRD KAB using
established Westernized measurement tools (n=66), 2) Develop a preliminary Samoan caregiver
ADRD KAB measurement tool (Samoan Tool), by 2a: incorporating Samoan epistemologies,
cultural values, contextual understandings of ADRD, and social determinants of health with
existing Westernized tools and constructs (focus groups, n=36), and 2b: assessing face and
context validity of the Samoan Tool with a panel of experts (n=24).
Our short-term goal is to determine ADRD KAB of Samoan caregivers, illuminate strengths
related to Samoan culture, and clarify factors enhancing or detracting from ADRD care
coordination and family unit well-being. Our long-term goal is to use these key insights to pilot
test and validate the Samoan Tool and to develop culturally appropriate interventions that
leverage cultural assets and promote family caregiving in the absence of sufficient formal
resources.

Public health relevance
PROJECT NARRATIVE Alzheimer’s Disease and Related Dementias (ADRD) have devastating impacts on family units, but little is known about ADRD caregiving in Indigenous populations, particularly in American Samoa. Our short-term goal is to determine ADRD knowledge, attitudes, and behaviors of Samoan family caregivers, illuminate strengths related to Samoan culture, and clarify factors enhancing or detracting from ADRD care coordination and family unit well-being. Our long-term goal is to use these key insights to pilot test and validate a Samoan caregiver ADRD KAB Tool and to develop culturally appropriate interventions that leverage cultural assets and promote family caregiving in the absence of sufficient formal resources.